Rho GTPase inhibitors for refrigerated platelet storage

ABSTRACT The use of platelet transfusions has increased dramatically since 1980s, but a safe, long-term platelet storage method remains missing. Current practice has platelets stored at 20 to 24°C after preparation, which has a limited lifetime up to 5 days primarily due to concerns about bacterial contamination. Refrigerated storage reduces platelet life-span because it causes glycoprotein-Ib (GPIb) receptors to cluster on specific microdomains of the platelet membrane. Recognition of specific glycated/syalylated residues on clustered glycoproteins by macrophage b2 integrins and hepatocyte Ashwell-Morell receptors results in platelet phagocytosis by the host and removal from circulation. Thus, prevention of glycoprotein clustering represents a useful target for chemical intervention. Platelet glycoproteins are intimately associated with intracellular cytoskeleton. Their clustering depends on the formation of lipid raft in the platelet membrane which in turn depends on the dynamics of the highly regulated processes of actomyosin assembly/disassembly. Rho family GTPases, including RhoA, Rac1 and Cdc42, are a class of GTP-binding enzymes that are central regulators of F-actin polymerization/depolymarization, and have been shown to control lipid raft formation and composition. Therefore, changes in Rho GTPase activities may influence platelet membrane lipid raft assembly and glycoprotein composition. Based on preliminary and published data, we hypothesize that reversible targeting of Rho family GTPases by small molecule inhibitors can prevent cytoskeleton-dependent refrigeration storage lesions in platelets and result in increased platelet survival. In this project, we will analyze the cytoskeletal functions and in vivo viability of murine and human platelets after refrigeration in the presence or absence of various combinations of specific inhibitors for Cdc42, Rac1 and RhoA GTPases. Combination of cell biology, drug discovery and platelet analysis expertise as demonstrated by multiple co-publications of the co-PIs resulting in an innovative, outside-the-box method for intervention in platelet storage technology. Chemical drug targeting of Rho GTPase activities through interference of protein-protein interaction is a revolutionary approach allowing for reversible inhibition of cytoskeletal rearrangements for which our group has pioneered and own the intellectual property licensed to P2D Inc.

Public health relevance
PROJECT NARRATIVE: Patients with low platelet counts often require platelet transfusion. This is crucial in the treatment of patients with cancer or massive trauma. The development of a method to prevent platelet damage upon refrigeration is a dream in blood banking and it would revolutionize the current method of platelet storage. The proposal intends to develop a method to store viable platelets by refrigeration by the addition of chemical inhibitors of several members of the Rho GTPase family. Completion of this project will move a novel method for platelet storage closer to FDA IND and commercialization. __SpecificAimsTextDelimiter__ Specific Aims The use of platelet transfusions has increased dramatically since 1980s, but a safe, long-term platelet storage method remains missing. Current practice has platelets stored at 20 to 24°C (RT) after preparation, which has a limited lifetime (up to 5 days) primarily due to concerns about bacterial contamination. Refrigerated storage reduces platelet life-span because it causes glycoprotein-Ib (GPIb) receptors to cluster on specific microdomains of the platelet membrane. Recognition of specific glycated/syalylated residues on clustered glycoproteins by host macrophage b2 integrins and hepatocyte Ashwell-Morell receptors results in phagocytosis of transfused platelets and their removal from circulation in the host. Thus, prevention of glycoprotein clustering may represent a useful "Cold receptor" target for improving platelet storage and transfusion. Guanine PLATELET nucleotide Platelet glycoproteins are intimately associated exchage factors CASIN (Cdc42 inhibitor) with the intracellular cytoskeleton organization. NSC23766 (Rac inhibitor) Their clustering depends on the formation of G04/Rhosin (Rho inhibitor) Rho Rho microdomains (so-called lipid rafts) in the platelet family family membrane which in turn anchors on cell GTPase GTPaseGDP GTP cytoskeleton which is dynamically regulated by intracellular signaling events related to actomyosin assembly/disassembly in an inside- out signaling fashion. Rho family GTPases, including RhoA, Rac1 and Cdc42, are a class of GTP-binding regulated enzymes that are central HOST PHAGOCYTOSIS regulators of F-actin polymerization and structural Figure 1. Working hypothesis. "Cold receptor" activation of GpIb clustering dynamics, and have been shown to control lipid through intracellular signaling mediated through Rho GTPases and the inhibitory raft formation and composition. Rho GTPase effect by Rho GTPase inhibitors. activities may influence platelet membrane microdomain assembly and glycoprotein composition/clustering. Our published and preliminary studies have identified lead specific chemical inhibitors for Rho GTPase family members Cdc42, Rac1, and RhoA, respectively, for which we own intellectual property rights. We have shown that pharmacologic inhibition of Cdc42, Rac1 and/or RhoA results in reversible inhibition of cytoskeletal-dependent platelet function in vitro and when combined, improves 24-hour platelet recovery in vivo. We hypothesize that specific targeting of multiple Rho family GTPases by reversible chemical inhibitors can prevent cytoskeleton-dependent refrigeration storage lesions of platelets and results in increased platelet survival (Figure 1). This project goal is to demonstrate a proof-of-concept that both murine and human platelets may be refrigerated safely by a treatment with Cdc42, Rac1, and/or RhoA inhibitors to suppress GPIb clustering, and upon a wash-removal of the inhibitors the platelets can survive in vivo functionally like their non-refrigerated counterparts in autologous (congenic) or xenogeneic setting. Actin/Myosin/ Tubulin/Spectrin Rearrangements Aim 1. Studies of murine platelet preservation after refrigeration. We will identify the Rho family GTPase member (or members) crucially responsible for platelet refrigeration damage by analyzing the effect of each of the Cdc42, Rac1, and RhoA inhibitors (CASIN, NSC23766 and G04/Rhosin, respectively, single or in combination) on platelet membrane GPIb clustering by using immunogold staining and electron microscopy and by in vitro phagocytic assays. We will also determine the recovery and survival of cold-stored, inhibitor-treated/washed murine platelets in blood after congenic transfusions. Aim 2. Studies of human platelet preservation after refrigeration. We will examine the effects of the Rho GTPases inhibitors on membrane GPIb clustering of human platelets, and analyze the 24-hour recovery and survival of refrigerated, stored platelets in various combinations of the Rho GTPases inhibitors in labeled human platelets upon xenogeneic transfusion. Our studies will demonstrate a new technology for the functional storage of platelets in cold temperatures, like it is done for red blood cells that would reduce the proliferation of bacteria and allow for a more extended period of storage. The technology may reduce the current platelet shortage in transfusion imposed by the short storage time (5-day) for platelets approved by the regulatory authorities in FDA.